Maintenance and Enrichment of the Maternal and Developmental Risks from Environmental and Social Stressors (MADRES) Cohort

PROJECT SUMMARY/ABSTRACT
Reducing health disparities and inequalities among marginalized populations is a top U.S. public health priority.
These disparities exist across a wide range of outcomes, including diabetes, hypertension, obesity, asthma,
heart disease, cancer, and preterm birth. Similarly, the burden of exposures to multiple environmental exposures
is not evenly distributed among populations. The Maternal and Developmental Risks from Environmental and
Social Stressors (MADRES) cohort is a prospective pregnancy cohort of more than 1000 predominantly low-
income, Hispanic/Latino mother-child pairs in urban Los Angeles, California. MADRES examines environmental
and social determinants of maternal and child health outcomes both during and after pregnancy. A wide range
of data are collected including interviewer-administered questionnaires and validated instruments,
anthropometric and body composition data, and a broad suite of biospecimens from both mother and child.
Environmental exposures were assigned to residential addresses of participants across time (e.g., ambient and
traffic-related air pollution) or measured in stored biospecimens (e.g., PFAS, metals, emerging chemicals of
concern). The MADRES cohort is a unique resource and one of the largest US environmental health disparities
cohorts of predominantly Hispanic mother-child pairs from structurally marginalized communities. The proposed
project would capitalize on the significant investment to date and would allow for re-engagement of inactive
participants, continued follow-up and maintenance of staff infrastructure, collection of biospecimens for future
studies, new opportunities for diversifying the environmental health sciences workforce, and increased capacity
for data sharing with the scientific community. We propose the following four specific aims: (1) Maintain, enrich
and support the continuation of the MADRES cohort of predominantly low-income Hispanic families; (2) Enhance
the existing MADRES biospecimen repository to annually collect blood and urine from mothers and blood, urine
and saliva from children to preserve for future studies; (3) Expand data sharing and quality assurance protocols
for the MADRES cohort; and (4) Provide opportunities for increasing workforce diversity for early-stage
investigators from the undergraduate to postdoctoral levels. We will work across the U24 consortium of cohorts
to promote data sharing best practices, development of novel metrics of structural racism and determine common
measures for conducting inclusive science.

Public health relevance
PROJECT NARRATIVE The MADRES cohort is a unique resource and one of the largest US environmental health disparities cohorts of predominantly Hispanic/Latino mother-child pairs from structurally marginalized communities. The proposed project would allow for continued follow-up and re-engagement with inactive participants, collection of biospecimens for future studies, new opportunities for diversifying the environmental health sciences workforce, and increased capacity for data sharing with the scientific community. As exposures to environmental chemicals and health outcomes disproportionately impact structurally marginalized groups, such population resources are necessary maintain to develop effective public health intervention and prevention strategies.